Nevada IDeA Networks of Biomedical Research Excellence (INBRE)

Overall Network Organization and Management Plan – Abstract
In this proposal the NV INBRE will continue to pursue the goals of enhancing biomedical research
infrastructure, research competitiveness, training and workforce development throughout the state of Nevada.
The specific focus of this research is Cell Growth and Differentiation. Every two- and four-year teaching college
and university in Nevada participates in this program as either Lead (University of Nevada, Reno), Partner
(University of Nevada, Las Vegas and Desert Research Institute) or Outreach Institution. The Developmental
Research Project Program (DRPP) will provide biomedical research opportunities designed to develop
research scientists and provide students research experiences at both Partner and Outreach Institutions.
Structured mentorship and collaboration programs enhance DRPP success. The Administrative Core will
provide operational support and will coordinate undergraduate research programs at Outreach and Partner
Institutions. Research faculty and students will present their research at the NV INBRE Annual Meeting as well
as at scientific meetings held at two different Outreach Institutions. The Data Science Core will provide
statewide research resources in bioinformatics, proteomics, genomics, cloud computing, and data storage and
processing and will provide workshops, education, and training to Outreach and Partner Institutions. Nevada is
a majority minority state and NV INBRE ensures that underrepresented populations are proportionally
represented in our Administrative Core and in all of our programs. Through these programs, NV INBRE will
continue to improve Nevada’s healthcare and biomedical workforce, infrastructure, and base.

Public health relevance
Overall Network Organization and Management Plan – Narrative The IDeA Network for Biomedical Research Excellence (INBRE) program enhances Nevada’s biomedical research, training, and infrastructure, which strengthens healthcare and biomedical workforce and leadership in the state and makes Nevada researchers more competitive for federal research funding.